Integrative and trans-ethnic study to understand psoriasis associated signals

PROJECT SUMMARY
Psoriasis is a chronic immune-mediated skin disease that has a significant impact on public health, with annual
direct and indirect costs over $75 billion dollars in the US. Advancements in high throughput technology have
enabled the identification of genetic and genomic components in the Th17/IL-23 and NF𝜅B axes, associated
with psoriasis pathology. Although >80 psoriasis susceptibility regions have been revealed, considerable
challenges remain in narrowing down the causal genetic variations and discerning their pathological mechanisms
that shape disease etiology. Similarly, while NF𝜅B signaling is involved in psoriasis and different skin immune
disorders, we have very limited understanding of the mechanistic role genetic variants play in NF𝜅B regulation.
With the new extended psoriasis GWAS emerging, psoriasis can serve as an ideal skin disease model to study
this phenomenon in keratinocytes. Psoriasis has a prevalence rate of 1.3% among African Americans (AA),
however most US-established genomics studies of psoriasis have been conducted on European American (EA)
populations. Our preliminary data show that the fine-mapping of components can be facilitated by integrating
genetic, epigenetic, and genomic information in a multi-ethnic analysis design, especially when including
individuals with African ancestry. We have illustrated elevated NF𝜅B signaling response in keratinocytes among
AA individuals and that inter-individual variations in inflammatory signature can have significant clinical
implications for the assessment of drug response. The long-term goal of this project is to identify biological
mechanisms for disease heterogeneity among psoriatic patients, and our overall objective is to utilize a trans-
ethnic design to advance the identification of psoriasis-associated regulatory mechanisms involved in the
modulation of NF𝜅B signaling in keratinocytes. We will apply an integrative approach to study multi-omics data
and leverage trans-ethnic information to fine-map the genetic/genomic components associated with inter-
individual inflammatory responses, providing a model to understand disease disparity among psoriatic patients
of different ethnicities. We will i) fine-map the response expression quantitative trait loci (reQTLs) modulating
NF𝜅B and other inflammatory signaling in keratinocytes; ii) determine regulatory mechanisms of psoriasis signal
that drive NF𝜅B signaling in keratinocytes at the cellular level using multi-modal genomic data; iii) utilize genetic
and genomic components participating in NF𝜅B signaling, to model clinical presentations and outcomes for
patients from an ongoing longitudinal psoriasis cohort. Successful completion of the project will have an
important positive impact by providing enhanced resolution and power to identify determinants of inter-individual
variations in inflammatory responses.

Public health relevance
PROJECT NARRATIVE The proposed research focuses on identifying the regulatory mechanisms of psoriasis-associated signals by utilizing an innovative strategy that leverages trans-ethnic and multi-genomic analysis. Successful completion of this project will significantly advance understanding of the genetic basis for inflammatory signaling in keratinocytes, as well as its impact on skin inflammation heterogeneity and clinical outcomes among psoriatic patients. Our proposal is highly relevant to the part of the NIH's mission that pertains to improving the understanding and management of human diseases.